MOLECULAR ANALYSIS OF MALARIA MITOCHONDRIAL GENE REGULATION

The human malaria parasite, Plasmodium falciparum, rapidly evolves drug resistance, creating
the urgent need for new treatment strategies. A critical barrier to identifying and developing new
drug development targets is a knowledge gap regarding most essential processes and regulatory
pathways. Ideally, new targets should be highly conserved and be unable or have limited ability
to mutate in order to evolve resistance. Parasite mitochondrial function is critically essential
across all the life stages and differs substantially from the human organelle; however, most
mitochondrial proteins have yet to be identified in malaria parasites. During the intraerythrocytic
development cycle (IDC), P. falciparum is supported by a single mitochondrion containing about
~20 copies of the 6 kb genome, characterized by extensive recombination. IDC parasite
mitochondria do not make cristae to insert electron transport chain (ETC) enzymes, thus the
organelle may have evolved unique transcription or translation repression systems to limit
expression of the mitochondrial encoded genes. Results from our integrative approach combining
whole genome sequencing and metabolic profiling, suggests a link between mitochondrial gene
expression regulation and resistance to ETC inhibitors, potentially due to recombination. Thus,
we hypothesize that 1) a feature of the multicopy status is retention of cryptic mitochondrial
genome copies encoding mutant alleles, which can be recombined for survival. 2) P. falciparum
mitochondria use previously uncharacterized gene expression systems, for repression and
activation which are unique to this organelle. The current objectives are to identify the source of
recombination between mitochondrial genomes and its contribution to drug resistance as well as
to determine the mitochondrial DNA repair pathways and transcriptional machinery of the
mitochondria using single-organelle approaches. This proposal will identify and define previously
unknown and uncharacterized aspects of parasite biology, with the goal of advancing rational
drug design. These studies will refine our knowledge about the basic mechanism of gene
regulation in the malaria mitochondria. Investigating the mechanisms underpinning these effects
will lead to the identification of highly conserved drug development targets.

Public health relevance
In the human malaria parasite, Plasmodium falciparum, the lack of knowledge regarding most essential processes and regulatory pathways, particularly in the mitochondria, is a critical barrier to identifying and developing new drug targets. Ideally these targets are highly conserved and should be resistant to mutation or have limited ability to change in order to evolve resistance. This proposal outlines methods to identify and define previously unknown and uncharacterized aspects of parasite mitochondrial biology, with the goal of advancing rational drug design against this deadly parasite.